Upgraded HVAC To Improve Animal Welfare In The WaNPRC Arizona Breeding Colony

ABSTRACT
The Arizona Breeding Colony in Mesa, Arizona houses the largest Specific-Pathogen Free breeding colony of
pigtail macaques (Macaca nemestrina) supported by the National Primate Research Centers from NIH in the
country. To maintain healthy animals, it is essential to have the infrastructure to maintain environmental
conditions. There are two buildings housing animals at this facility. The Ellingson Building which was opened
in 2019 houses animals indoors with HEPA-filtered positive pressure air to prevent exposure of animals to
Coccidioides posadasii, the organism that causes Valley Fever. In the older building (Building A) some animals
are housed in indoor/outdoor enclosures and some are housed entirely indoors. Exposure to Coccidioides is
decreased by keeping animals indoors during dust storms and wetting down outdoor enclosures before allowing
the animals access. However, the current HVAC units providing air indoors are reaching the end of their usable
life. We are requesting funds to purchase and install a new HVAC to replace two aging units. This will allow us
to increase energy efficiency and ensure consistent delivery of HEPA-filtered air to the animals to improve animal
health and welfare.

Public health relevance
PROJECT NARRATIVE To maintain healthy animals, it is essential to have the infrastructure to maintain environmental conditions. We are requesting funds to purchase and install a new HVAC unit to replace two aging units that are approaching the end of their useful life. This will allow us to increase energy efficiency and ensure consistent delivery of HEPA-filtered air to the animals enhancing animal welfare.